Integration of Inflammatory Signaling and the Unfolded Protein Response by Nitrosylation Signaling in Obesity

PROJECT SUMMARY
In the setting of obesity, endoplasmic reticulum (ER) stress has been identified as a prominent feature in
metabolic tissues in both animal models and in humans. To cope with ER stress, cells activate the unfolded
protein response (UPR) to mitigate stress. However, failure of the UPR results in chronic unresolved stress,
contributing to the development of obesity-induced insulin resistance. Nitric oxide (NO) is a key mediator of
obesity-associated inflammation. We recently demonstrated that NO-mediated protein modification (S-
nitrosylation) impairs the RNase activity of inositol-requiring enzyme-α (IRE1α), resulting in unresolved ER
stress and insulin resistance. Although nitric oxide synthase (NOS) provides the general intracellular NO pools
for protein S-nitrosylation, the rate of these modifications is also affected by the targeted removal of NO groups
by protein denitrosylation. Our strong preliminary data demonstrate that obesity impairs the activity of S-
nitrosoglutathione reductase (GSNOR, a major denitrosylase), leading to elevated nitrosative stress in the liver.
Furthermore, deletion or overexpression of GSNOR directly regulates the S-nitrosylation state of IRE1α and
ER function in mice with diet-induced obesity (DIO). Notably, liver-specific GSNOR overexpression ameliorated
obesity-associated insulin resistance. However, the molecular mechanism that underlies the regulation of ER
homeostasis by GSNOR-mediated denitrosylation signaling is unknown. We propose to test the central
hypothesis that obesity attenuates GSNOR-dependent protein denitrosylation, resulting in elevated nitrosative
stress in the ER that contributes to obesity-associated hepatic insulin resistance. To test this hypothesis, we
will undertake 2 specific aims. In Aim 1, we will: 1) determine whether liver-specific GSNOR deletion impacts
hepatic insulin sensitivity and whole body glucose homeostasis using DIO mouse model; 2) establish whether
GSNOR regulates hepatic insulin action directly via modulation of UPR; and 3) assess the therapeutic potential
of enhancing hepatic GSNOR activity in obese mice by glutathione supplementation and enhancing cellular
nicotinamide adenine dinucleotide (NAD) metabolism. In Aim 2, we will: 1) profile the ER S-nitrosylation
proteome and characterize the endogenous S-nitrosylation sites on IRE1α; 2) address how GSNOR-mediated
denitrosylation signaling modulates the IRE1α RNase activity; and 3) establish how GSNOR-mediated
denitrosylation signaling affects IRE1α interactome formation. The approaches used here are innovative,
combining the use of cellular and molecular biological analysis, biochemical analysis for S-nitrosylated proteins,
elucidating the ER S-nitrosylation proteome, protein-RNA interaction analysis, and in vivo mouse metabolic
profiling. The mechanisms elucidated in this project will provide further understanding of how inflammatory and
ER stress pathways are integrated in the context of obesity-associated hepatic insulin resistance, dyslipidemia
and ultimately type 2 diabetes. Insight into the mechanisms by which maladaptive organelle stress responses
drive these pathologies should speed development of novel therapeutic targets for metabolic diseases.

Public health relevance
PROJECT NARRATIVE: The proposed project is relevant to public health in that it is expected to reveal a novel molecular mechanism that underlies the association between inflammation and endoplasmic reticulum homeostasis in the context of obesity, and to thereby advance knowledge in the fields of obesity and diabetes. Thus, the proposed research is relevant to the NIH mission of developing fundamental knowledge that will help to reduce the burdens of human disability.